Genesis of Esophageal Pain: Longitudinal Muscle Spasm and Wall Ischemia

DESCRIPTION (provided by applicant): Seventy percent of patients coming to the emergency room with chest pain have normal coronary arteries and thus have non-cardiac pain. Esophagus is suspected to be the cause of pain in these patients. Gastro- esophageal reflux and esophageal spasm are 2 possible major causes of esophageal pain. With the availability of potent acid inhibition therapy (proton pump inhibitors) it is possible to treat acid reflux effectiely. However, large number of patients continues to experience chest pain symptoms and come to the medical emergency room frequently. One of the possible causes of chest pain in these patients is esophageal spasm, however large number of studies conducted in 1990's failed to identify abnormal motor event at the time of pain. Current thinking is that esophageal hypersensitivity, central or peripheral, is the cause of pain in these patients. Using simultaneous ultrasound imaging and manometery we found a unique sustained esophageal contraction (SEC) in association with esophageal pain and heartburn in the late 90's. The SEC was later determined to be actually a prolonged contraction of the longitudinal muscles of the esophagus and thus could not be recorded by intraluminal manometry. During last funding period, we have made number of observations with regards to the role of longitudinal muscles of the esophagus in health and disease. One of the problems is that recording of longitudinal muscle contraction with US imaging, especially over extended periods of time in humans, is quite tedious. Other laboratories have not made an attempt to study longitudinal muscle spasm and its relationship with esophageal pain, thereby preventing wide acceptance of our observations. High resolution manometry is a relatively novel technique to record contraction of the circular muscles of esophagus at closely spaced intervals. Our observations suggest that HRM can also record longitudinal muscle contraction related esophageal shortening of the esophagus. The goals of our study are; 1) to determine the temporal correlation between esophageal pain/heartburn and longitudinal muscle spasm of the esophagus using a novel form of HRM, i.e., ambulatory HRM. The latter can be performed for extended periods of time and thus making it possible to determine the temporal correlation between spontaneous pain and motor events. How does longitudinal muscle spasm cause pain? We propose that muscle spasm induces ischemia of the wall of the esophagus. 2) Using Laser Doppler technique we plan to study the effects of muscle contraction on the blood flow in the wall of esophagus in the animal experiments. 3) Finally, we will determine the temporal correlation between longitudinal muscle spasm, esophageal wall ischemia and non cardiac or esophageal pain. With the better understanding of pathogenesis of pain, we hope more effective strategies to treat esophageal pain will be forthcoming. PUBLIC HEALTH RELEVANCE: Our preliminary studies show that esophageal wall ischemia related to prolonged contraction of the longitudinal muscles of the esophagus is temporally related to esophageal pain/heartburn. We use novel technique of ambulatory high resolution manometry to demonstrate the temporal correlation between esophageal pain and longitudinal muscle spasm. Laser Doppler technique is used to study the effects of esophageal contractions on the esophageal blood flow to demonstrate temporal correlation between esophageal pain and esophageal wall ischemia in humans.

Public health relevance
Our preliminary studies show that esophageal wall ischemia related to prolonged contraction of the longitudinal muscles of the esophagus is temporally related to esophageal pain/heartburn. We use novel technique of ambulatory high resolution manometry to demonstrate the temporal correlation between esophageal pain and longitudinal muscle spasm. Laser Doppler technique is used to study the effects of esophageal contractions on the esophageal blood flow to demonstrate temporal correlation between esophageal pain and esophageal wall ischemia in humans.